A Multisite Randomized Trial of Viral Combat: A Mobile Gaming App to Improve Adherence to PrEP

Project Summary
Pre-exposure prophylaxis (PrEP), in which persons with ongoing HIV risk use antiretroviral medications to
reduce their risk of acquiring HIV infection, is a promising prevention strategy. However, data show that PrEP’s
effectiveness is greatly compromised by suboptimal adherence to treatment.1 Persons on PrEP face many
challenges to optimal adherence and retention in care, including stigma and misperceptions about risk.2,3 Due
to these challenges, the prescribing of PrEP should be accompanied by adherence interventions that are
appealing to diverse populations.1,4 We developed and examined the preliminary efficacy of an action-oriented,
appealing, mobile game to improve adherence to PrEP entitled Viral Combat.5,6 Viral Combat was tested in a
randomized trial with 69 participants newly initiating PrEP. At the 24-week follow-up, those in the intervention
group were 3.75 times (p=0.02) as likely to engage in optimal PrEP dosing (i.e. 4 or more days/week as
indicated using levels of tenofovir diphosphate from dried blood spots) compared to the control group.6 In this
next phase of research, we will test Viral Combat through a multisite Hybrid Type 1 effectiveness-
implementation randomized controlled trial (RCT) with 200 participants ages 15-34 years, receiving PrEP care
at clinical sites in the South (n=100 Jackson, MS) and New England (n=100, Providence, RI; Boston, MA). The
integrated Promoting Action on Research Implementation in Health Services (i-PARIHS) framework will
examine the facilitators and barriers to the intervention’s implementation. Formative interviews with
stakeholders will inform this intervention prior to the trial, and post-evaluation interview will summarize issues
relevant to future dissemination. 45

Public health relevance
Project Narrative Pre-exposure prophylaxis (PrEP) is a medication that can greatly reduce the risk of acquiring HIV infection; however, PrEP’s effectiveness is reduced by poor adherence. We developed a mobile game that improved adherence to PrEP. In this proposed project, we will further test the game with a larger number of people, and the individual, organizational and structural factors associated with the implementation of the gaming app will be collected through in-depth interviews with patients, staff, and clinic administrators.